Probing the circadian clock in zebrafish larvae with in situ single cell transcri

DESCRIPTION (provided by applicant): Disruption of normal sleep and circadian rhythms is a major factor affecting drug addiction and recovery. It has recently been shown that essentially all cells in our body have a circadian clock. Using zebrafish as a model system, we will apply and optimize a new technology in single cell gene expression analysis to characterize the diversity of behaviors in circadian clocks amongst cells in an organism. In particular, we will apply a method to profile mRNA expression levels in situ to measure the abundance of 25 circadian clock genes simultaneously in each cell of intact zebrafish larvae. This will provide a global assessment of circadian rhythms in all cells of an intact vertebrate animal at an unprecedented level of detail and robustness. We will test several hypotheses regarding circadian clock gene expression in vivo and its modulation by drugs associated with addiction and reward. We will also test the hypothesis that modulating circadian rhythms affects behaviors associated with reward and addiction. These studies could reveal novel circadian mechanisms that affect drug abuse and addiction and may lead to new therapies for these disorders. If successful, this technology can be extended to other model organisms to study large-scale gene expression changes associated with many complex behaviors.

Public health relevance
PUBLIC HEALTH RELEVANCE: We will adapt and optimize a technology to simultaneously visualize the expression of many genes in each cell of an intact vertebrate animal. As proof-of-concept, we will monitor the expression of many circadian clock genes in each cell of transparent zebrafish larvae and test several hypotheses regarding circadian clock mechanisms and their links to drug abuse and addiction. If successful, this technology will provide a valuable new tool in efforts to understand and combat drug abuse and addiction disorders.